Expanding the Therapeutic Window of Nanoparticle STING Agonists for Cancer Immunotherapy

PROJECT SUMMARY
Immune checkpoint blockade (ICB) is an immunotherapy that is revolutionizing cancer treatment, but is
effective in a minority of patients. Across many cancer types, this can largely be ascribed to an insufficient
number or function of tumor infiltrating T cells positioned for reactivation by ICB antibodies. Therefore, there is
a critical need for strategies to increase tumor immunogenicity that results in a greater number of patients that
benefit from immunotherapy. Our long-term research goal is to improve responses to immunotherapy through
the molecular engineering of materials that harness endogenous mechanisms of antitumor innate immunity. To
that end, we have developed STING-activating nanoparticles (STING-NPs) – a new class of endosome-
destabilizing polymer vesicles (polymersomes) that enhance the cytosolic delivery of cyclic dinucleotide (CDN)
agonists of the stimulator of interferon genes (STING) pathway. CDNs have poor drug-like properties and
therefore suffer from poor cellular targeting, rapid clearance, and inefficient transport to the cytosol
where STING is localized. This has restricted clinical evaluation of CDNs to local, intratumoral administration,
which is not feasible for many cancer patients with advanced disseminated disease. STING-NPs enhance the
potency of CDNs by several orders of magnitude, resulting in increased tumor immunogenicity, inhibition of
tumor growth, and improved response to ICB. Our objective in this R01 application is to further expand the
utility and therapeutic window of STING-NPs by 1) optimizing their properties for safe and effective systemic
administration via an intravenous route, and 2) designing new combination therapies that leverage their
immunopharmacological properties to improve immunotherapy responses in melanoma models that are
resistant to ICB. We will accomplish this through the following Specific Aims. First, we will re-engineer the
polymersome corona to optimize the pharmacokinetics and biodistribution profile of intravenously administered
STING-NP to achieve maximal CDN delivery and STING activation in the tumor microenvironment. Second,
we will synthesize a new class of modified CDNs that are structurally optimized for increased incorporation and
retention into STING-NPs, and will investigate the effect of CDN structure, loading, and stability on
immunostimulatory activity and therapeutic efficacy. Third, we will develop rationally designed and clinically
relevant chemo- and immunotherapy combinations that target mechanisms of resistance to STING agonists
that we have recently identified. Overall, these studies will advance STING-NPs as a platform for increasing
tumor immunogenicity and improving outcomes of immunotherapy. In doing so, these investigations will also
advance our understanding of relationships between nanocarrier properties, pharmacological behavior,
antitumor immunity, therapeutic activity, and toxicity with potential to inform design criteria that are broadly
applicable to STING and other innate immune agonists.

Public health relevance
PROJECT NARRATIVE Most cancer patients do not respond to currently approved immune checkpoint inhibitors, motivating a need for new approaches to stimulate robust and durable immune responses against tumors. This proposal aims to develop and optimize a new class of immunotherapeutic nanotechnology that jump starts natural mechanisms of antitumor immunity. If successful, this approach has potential to increase the number of patients that benefit from cancer immunotherapy.